ASSESSMENT OF HYDROGEN PEROXIDE GENERATION IN NEUTROPHILS BY FLOW CYTOMETRY

An assay for evaluating hydrogen peroxide production by human neutrophils after stimulation using flow cytometry was developed and applied to patients with chronic granulomatous disease (CGD) and the X-linked obligate carriers. The flow cytometric dihydrorhodamine (DHR)-based assay for evaluation of oxidative burst is a sensitive method for evaluating phagocytes in patients with possible CGD. This assay also appears to be a good screen for the genotype of the disease. In addition, the method was optimized and is sensitive to 1 normal cell in <=10,000 abnormal cells making it an ideal assay for monitoring CGD patients after gene therapy, as well as for identifying normal cells after allogeneic granulocyte transfusion.